NUMERICAL TOOLS FOR NEW CELL BIOLOGICAL MODELING CAPABILITIES IN VCELL

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This project is aimed at implementing new capabilities within VCell for modeling cell phenomena. In particular, algorithms for solving linear elliptic (Poisson-type) equations will be implemented that are required for modeling effects of cell biomechanics and electrophysiology. Elliptic solvers are also required to find a steady-state solution of a reaction-diffusion system. In addition, other new capabilities, such as different types of boundary conditions, block solvers, etc., will be implemented.